circSATB2, a novel regulator of arsenic-induced carcinogenesis

ABSTRACT
Inorganic arsenic (iAs) is an environmentally ubiquitous toxin that affects >100 million people worldwide, with
health consequences ranging from acute toxicity to cancer. While iAs exposure can generate reactive oxygen
species that damage DNA, a significant fraction of iAs-induced disease cannot be attributed to DNA lesions. We
previously showed that iAs exposure remodels DNA and histone epigenetic marks in iAs-induced oncogenesis,
and now know that iAs exposure also alters higher-order (3-dimensional, or 3D) chromatin structure. One of
those structures involves a dynamic link between chromatin and the inner nuclear matrix, which brings distal
genes into proximity with one another. This link is maintained by the SATB proteins; is necessary for proper gene
regulation during cellular differentiation; and is disrupted by iAs exposure. SATB1 is a known oncogene, whereas
SATB2 can either act as an oncogene or tumor suppressor depending on the cell type and gene environment.
We recently discovered that during iAs-induced oncogenesis, SATB2 is upregulated and produces a novel,
circular RNA (circSATB2) that “protects” linear SATB2 mRNA from degradation, possibly by interfering with a
microRNA (miR31). The circSATB2 RNA is translated into a peptide (circSATB2p), and this peptide alters the
native SATB2 interactome and gene expression profile. These data support the idea that transcriptional and
post-translational, temporal control over SATB2 and chromatin higher-order structures are critical for
coordinating normal cellular differentiation. They suggest that SATB2 is regulated by a novel circRNA-miRNA-
mRNA regulatory axis. The objective of this project is therefore to determine exactly how iAs exposure regulates
SATB2 expression and activity to promote oncogenesis. In Aim 1, we will test how SATB2 is regulated
transcriptionally (via the circRNA-miR-mRNA pathway) and post-transcrionally (via regulation of the protein). In
Aim 2, we will test how circSATB2p and SATB2 differentially regulate the 3D genome organization and nuclear
integrity, and in Aim 3, we will test the role of circSATB2 in metastasis and tumorigenesis. These studies will
identify the circSATB2-mirRNA-SATB2 gene regulatory axis, and establish that a novel SATB2 isoform switch
drives iAs-induced oncogenesis. The mechanistic understanding of how iAs affects 3D chromatin structure and
nuclear integrity will elucidate key (and novel) processes in chromatin biology, and contribute to a framework for
developing diagnostics and targeted therapeutics for iAs-induced disease.

Public health relevance
PROJECT NARRATIVE Inorganic arsenic is an environmentally ubiquitous toxin that affects >100 million people worldwide, with health consequences ranging from acute toxicity to cancer. We discovered that arsenic exposure disrupts a key protein and three-dimensional (3-D) structure of the genome via novel “circular RNA” regulatory mechanism, thereby altering normal gene expression and cellular activity. In this project, we will define the molecular mechanism and prove that the arsenic-induced “circular RNA” regulatory switch is responsible for disease.